Roles of HIV-1 capsid-binding FG-motif containing cellular cofactors in infection

Abstract
Early events in HIV-1 lifecycle, such as post-fusion trafficking of viral cores across the cytoplasm, through
the nuclear pore complex (NPC) and into the nucleus, remain poorly understood due to limited information
about virus-host interactions. Interactions of the core’s surface, which is composed of the capsid protein
(CA) arranged into large hexameric lattices and exactly 12 pentamers, with a variety of host cell proteins
that aid infection (dependency factors) are crucial for this journey. However, their full identity and molecular
mechanisms of action remain largely unknown. Our preliminary studies resulted in the following two
principal discoveries. 1) We have identified SEC24C as a new, crucial HIV-1 host dependency factor.
SEC24C is a predominantly cytoplasmic protein that employs a phenylalanine-glycine (FG)-motif to
specifically interact with the hexameric CA lattice at the hydrophobic pocket comprised of two adjoining
subunits. These novel findings, coupled with the known roles of other CA-binding FG-motif containing
cellular factors NUP153 and CPSF6 in nuclear import and integration site selection of HIV-1, suggest that
these proteins collectively provide a dependable platform for continuous HIV-1 journey throughout different
cellular compartments during the virus ingress to ensure productive infection. 2) We discovered a prion-
like domain (PrLD)-mediated mechanism for avid binding of SEC24C, NUP153 and CPSF6 to hexameric
CA lattices. Our preliminary cryo-EM and HDX-MS studies provide novel structural information indicating
that, in addition to known CPSF6 FG peptide binding to the cognate CA hydrophobic pocket, PrLD-PrLD
interactions enable polyvalent assembly of CPSF6 molecules along the extended lattices of adjoining CA
hexamers. Our virology experiments further support an essential role of CPSF6 PrLD in functional virus-
host interactions in infected cells. To extend these exciting, paradigm-shifting preliminary studies we
propose the following three specific aims: Aim 1 will define a role of SEC24C in HIV-1 infection; Aim 2 will
elucidate interplay between SEC24C and other CA-binding host factors; Aim 3 will determine the structural
basis for avid recognition of hexameric HIV-1 CA lattices by FG-motif and PrLD containing cellular factors
SEC24C, NUP153 and CPSF6. To accomplish these aims we have assembled a highly collaborative team
with complementary expertise in virology, proteomics, biochemistry and X-ray crystallography
(Kvaratskhelia), cryo-EM (Asturias), live cell microscopy (Melikian) and HDX-MS (Griffin). These studies
are expected to uncover novel virus-host interaction mechanisms crucial for HIV-1 infection. Furthermore,
elucidating structural determinants for functionally relevant interactions of SEC24C, NUP153 and CPSF6
to hexameric CA lattices will provide a new frontier in HIV-1 structural biology and improve our
understanding of these virus-host interactions as an important therapeutic target.

Public health relevance
Project Narrative We will investigate the mechanism by which HIV-1 recruits key host factors to its capsid to ensure effective completion of early steps of infection. Structural and functional insights into critical virus-host interactions will facilitate ongoing efforts in the pharmaceutical industry to develop improved, long-acting, highly active antiretroviral therapies.